Cerebellar Synaptic Dysfunction in Autism Spectrum Disorder

Project Summary
Autism spectrum disorders (ASD) are a highly complex and multi-faceted group of related neurodevelopmental
disorders with numerous genetic, epigenetic, and environmental etiologies. Despite such complex underlying
causes, one common theme among ASD variants is that it is a disorder of synaptic development. This
observation strongly motivates testing whether experimental models of ASD disrupt the normal synaptic and
biophysical development of neural circuits, with the goal of understanding whether and how such perturbations
alter circuit function into adulthood. One particularly compelling circuit, which has recently become a major
focus in the field of ASD research, is the cerebellum. Although traditionally viewed as a motor structure,
emerging clinical and preclinical data suggest that the cerebellum plays an important role in cognitive and
emotional processing. Disruptions in cerebellar activity during development may also centrally contribute to
ASD – as the developing cerebellum is a common locus the expression of ASD risk factor genes.
Furthermore, ASD results in decreased numbers and synaptic complexity of Purkinje cells as well as their
postsynaptic targets, cerebellar nuclear cells, the two cell populations that form the cerebellar cortico-nuclear
circuit, a disruption which persists into adulthood. These observations have resulted in the cerebellar
diaschisis model of ASD, which posits that disruptions in cerebellar circuit function, particularly during early
critical periods of synaptic development, may causally contribute to ASD. If the cerebellar diaschisis model is
correct, then perinatal circuit function in the developing cerebellar cortico-nuclear circuit is likely perturbed.
Therefore, the goal of the proposed research is to explicitly test whether ASD results in aberrant cortico-
nuclear circuit formation and electrophysiological maturation during early developmental critical periods, and
test whether these changes persist into adulthood. More specifically, the proposal will test the hypothesis that
ASD is associated with aberrant developmental glutamate release during early sensitive periods of circuit
formation. In other inhibitory circuits, developmental glutamate release is critical for proper circuit maturation,
however, this hypothesis has not been tested during cerebellar development or in the context of ASD.
Together, the proposed experiments have the potential to provide a biophysical and mechanistic grounding for
the cerebellar diaschisis model of ASD, which may provide novel therapeutic targets for the treatment of ASD.

Public health relevance
Project Narrative Understanding the neural and developmental mechanisms underlying autism spectrum disorder is critical for developing novel therapeutic strategies. Although traditionally viewed as a motor structure, emerging clinical evidence suggests the cerebellar circuits may be disrupted in autism spectrum disorders. Here we will test whether autism spectrum disorder alters the normal functional development of the cerebellum, particularly during early sensitive periods of synapse development.